ANALYTICAL PROTEIN PROFILING

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Analytical Chemistry/Protein Profiling Core Core Leaders: Michael Powell, Winston Thompson, Daniel Von Deutsch Working Group: Drs. Michael Powell, Winston Thompson, Gale Newman, Rigobert Lapu, Dan von Deutsch, Jacqueline Hibbert, Xuebiao Yao Description: Our core provides support to investigators seeking to find biomarkers for a wide variety of diseases. Assays range from individual measurements of single analytes to Proteomics analysis of complex biological samples. We use techniques such as ELISA, Luminex, protein gels, HPLC, and others to provide a wide range of services.